Rac1 Inhibition for the treatment of medulloblastoma

PROJECT SUMMARY
Despite considerable advances in identifying genetic and epigenetic abnormalities in medulloblastoma, many
patients succumb to the disease. In addition, patients who respond to traditional therapy suffer from cognitive
and intellectual deficits. Therefore, there is a dire need to identify novel therapies for treating medulloblastoma.
Rho family GTPases are targets in multiple cancers including medulloblastoma. Rho, Rac1 and Cdc42 are
essential mediators of cell-cell adhesion and cellular motility signaling, which are dysregulated in
medulloblastoma. These GTPases are involved in the regulation of the cytoskeleton, cell migration, cellular
proliferation, and developmental signaling. The small GTPase Rac1 has recently been reported as a possible
therapeutic target in medulloblastoma due to its regulation of Hedgehog signaling via the GLI1 and GLI2
transcription factors. We have recently reported that GLI1/GLI2 are in a novel complex that contains the
epigenetic regulators UHRF1 and DNMT1. Therefore, Rac1 may play a previously unappreciated role in
epigenetic regulation of medulloblastoma by controlling the GLI1/GLI2/UHRF1/DNMT1 complex. To test this, we
will utilize a novel brain penetrant Rac1 inhibitor we developed termed GYS32661. We will test the hypothesis
that GYS32661 will reduce GLI1/GLI2 nuclear localization, attenuate Shh signaling in medulloblastoma in vitro
(Aim 1) and reduce medulloblastoma growth in vivo (Aim 2). Collectively, our studies will test whether Rac1
inhibition is a novel therapeutic strategy for treating medulloblastoma.

Public health relevance
PROJECT NARRATIVE The most common malignant brain tumor affecting children and adolescents is medulloblastoma. We will test the efficacy and safety of a novel small molecule inhibitor of Rac1 GYS32661 in cells and in mouse models of medulloblastoma. Our studies will lay the foundation for clinical trials of Rac1 inhibitors for the treatment of medulloblastoma.